Addressing the continuum of care among high-risk Thai men

Project Summary
The HIV epidemic in Thailand is escalating among young men who have sex with men (YMSM).
Particularly, HIV prevalence among YMSM is estimated to be 10-15% in Northeastern Thailand. Obviously
high risk sexual behavior is occurring, and the uptake of HIV testing remains low even though free testing
services are offered by public clinics. Despite provision of free antiretroviral treatment (ART) by the
government, less than 25% of HIV-positive YMSM (HIV+YMSM) are retained in care, suggesting very few
have achieved viral suppression. The suboptimal access to HIV testing and treatment services among
YMSM pose tremendous challenge in much needed prevention efforts to improve linkage to care and
achieve individual and community viral suppression to prevent onward HIV transmission. Community
mobilization and an empowerment approach that targets barriers at individual, social/community, and
health systems levels are needed to improve access to prevention and treatment services, including sexual
risk reduction, HIV testing, and linkage and engagement in the care continuum (CC). Based on a cultural
adaptation of the evidence-based Mpowerment intervention, we developed and piloted HUG-M, a multi-
level, theory-based intervention that diffuses social support and empowers the YMSM community in order
to establish social norms supportive of risk reduction and biannual HIV testing. HUG-M was acceptable to
YMSM in a prior pilot study, feasible to implement, and has the potential to increase HIV testing and
decrease sexual risk behavior. The proposed study will test a community mobilization, multi-level
intervention in two well-matched cities in Northeastern Thailand. The project’s aims are: (1) to finalize and
manualize HUG-M+, a community mobilization, multicomponent, multi-level, combination intervention that
focuses on the entire Continuum of Prevention and Care, (2) to implement HUG-M+ for 2 years in
collaboration with the Thailand Ministry of Public Health (MOPH) clinics that provide HIV testing and
treatment, and (3) to evaluate the pilot efficacy of HUG-M+ in decreasing sexual risk behavior; increasing
HIV testing to at least biannually; and increasing prompt, sustained engagement in care among men living
with HIV by (a) longitudinal cohorts of YMSM in two cities in Northeastern Thailand; oversampling
HIV+YMSM, which will provide data on the CC including sexual risk behavior; anal bacterial STIs; HIV
testing frequency; and engagement in care among HIV+YMSM; and (b) longitudinal public health data,
already collected by the MOPH, which include CD4 and viral load data for HIV patients. If this pilot is shown
to be effective, a follow-up larger, multisite study of it may be proposed.

Public health relevance
Project Narrative Young Thai men who have sex with men (YMSM) are at extraordinarily high risk for HIV. Yet the Thailand National HIV Strategy does not support adequately cover HIV prevention for YMSM using specific methods relevant to them, and instead uses a one-size-fits all approach. Partnering with the Thailand Ministry of Public Health (MOPH), the proposed study seeks to finalize, implement and evaluate a multicomponent, multi-level, community mobilization, combination intervention (HUG-M+) to address the entire Continuum of Prevention and Care. We propose to test the efficacy of this approach by conducting research in two cities in Northeastern Thailand, one of which was randomized to the intervention condition, which will receive HUG-M+ and the other was randomized to the control condition, where standard of care will be provided. If HUG-M+ is found to be efficacious, it might be scaled up, with the support of the MOPH, to other regions in Thailand, elsewhere in Asia and the US. We will also attempt to locate funding in order to conduct a cluster- randomized controlled study in Thailand, or in Thailand and other countries in Southeast Asia experiencing rapid increases in HIV among young men.